Catalytic C-C Coupling via Hydrogen Transfer

Summary/Abstract: Catalytic hydrogenations are the most frequently utilized chemical reactions
in the synthesis of pharmaceutical ingredients, constituting 14% of GMP reactions (oxidations =
3% of GMP reactions). Metal-catalyzed cross-coupling and carbonyl addition are the most
frequently utilized methods for C-C bond formation among GMP reactions. We seek to develop a
family of catalytic methods for C=X/C=C (X = O, NR) and C-X/C-Y (X = Y = halide) reductive C-C
couplings mediated by H2, 2-PrOH, NaO2CH that are as clean, scalable and cost-effective as
catalytic hydrogenation. This includes catalytic hydrogen auto-transfer reactions that affect direct
conversion of lower alcohols/amines to higher alcohols/amines via CH-XH/C=C (X = O, NR) C-C
coupling. These methods inform parallel studies on the total synthesis of polyketide natural
products with anti-cancer or anti-bacterial properties. Under the NIH-MIRA program, our work on
catalysis (R01 GM069445) and total synthesis (RO1 GM093905) will be integrated to maximize
their synergy.

Public health relevance
Project Narrative: Our laboratory has pioneered a broad, new class of catalytic methods for C- C bond formation that occur through the addition or redistribution of hydrogen. Our methods are used widely by other researchers, and we remain the primary research team advancing this field. The catalytic methods we develop support an integrated program of research in which reaction discovery informs total synthesis, which informs medicinal chemistry.